Mini-Livers Derived from Human IPS Cells for Modeling Steatosis and Therapy

ABSTRACT/SUMMARY
Our long-term goal remains the same and targets to develop human liver tissue model from stem cells, with
multi-cellular cues, metabolic functionality, that incorporates dynamic genetic and epigenetic factors and
encompasses the spectrum and evolution of human NAFLD to uncover disease mechanism and therapeutics.
The objectives of the proposed study are to continue developing human fatty livers engineered with iPS cells,
that incorporates the dynamic expression of the epigenetic-related histone modification SIRT1 in different
genetic polymorphisms and elucidate their role as metabolic regulators in the development of human fatty liver
disease. The central hypothesis to be tested here is that genetic polymorphisms especially the NAFLD-high-
risk PNPLA3 rs738409, combined with epigenetic-related changes (SIRT1) can control hepatic metabolism
and contribute to the development of human fatty liver. The rationale is that the ability to generate human
diseased liver tissue using genetically modifiable iPS cells from different human populations with single-
nucleotide-polymorphisms is a powerful resource, that now make it possible, for the first time, to functionally
interrogate their role in disease. Importantly, based on our strong preliminary data of targeted metabolomic
analysis in isolated human hepatocytes obtained from either liver resections “Normal Human Hepatocytes” or
hepatocytes isolated from explanted NASH livers “NASH Human Hepatocytes” carrying either the NAFLD-high
risk PNPLA3 I148M genetic variant or wild type we hypothesize that PNPLA3 I148M hepatocytes have high
levels of ferroptosis thereby leading to low metabolic capacity to adapt to stressors and continuous loss of
hepatocytes. In the newly proposed aim3, we aim to uncover ferroptosis based therapeutic strategies for
patients with NAFLD-high risk PNPLA3 I148M genetic variants.
The work described here is expected to i) generate human iPS cells carrying shRNA mediated conditional
knockdown of SIRT1 in different genetic backgrounds (especially the NAFLD-high-risk PNPLA3 rs738409
variant), ii) develop a novel approach for modeling an organ-like environment to determine the role of the
epigenetic related factor SIRT1 and the genetic variants in the development of fibrotic human mini-livers with
fatty liver disease and iii) determine the role of genetic polymorphisms in regulating functional metabolism in
mini-human iPS-derived liver tissue with fatty liver disease with especial focus on ferroptosis. Understanding
this process alone or in relation to epigenetic changes in a human liver tissue model can result in preventive
therapeutic strategies for patients with NAFLD-high risk PNPLA3 I148M genetic variants. The results of this
work will also have a positive impact by establishing the basis and platform for future sophisticated organ
engineering techniques that incorporates several different cell types from the same iPS cell source, these
techniques could be applied to study other liver diseases (e.g. metabolic diseases) and is expected to be a
major contribution to the fields of stem cells engineering and liver steatosis.

Public health relevance
PROJECT NARRATIVE (RELEVANCE STETAMENT) Liver diseases cause about 30,000 deaths annually in the US, and the progression of fatty liver (nonalcoholic steatohepatitis, NASH) is the most common cause of liver dysfunction worldwide. To date the factors that promote fat deposition in the liver and the transition from steatosis to NASH and cirrhosis in humans are unknown in specific human genetic backgrounds. One obstacle to study such pathological transition is the absence of appropriate human liver tissue model. Environmental (epigenetic) factors, and genetic disease drivers have been associated to the NAFLD development and progression. This project aims to improve public health by utilizing organ engineering technology and stem cell engineering to constitute mini-livers that mimic human fatty liver disease with success to determine the role and mechanism of NAFLD-high risk or protective genetic variants.